Indiana University clinical Center for acute pancreatitis and diabetes clinical research network

PROJECT SUMMARY / ABSTRACT
Diabetes mellitus (DM) is a known and underrecognized complication of acute pancreatitis (AP), exhibiting a
spectrum of features that overlap with both type 1 and type 2 DM (T1D, T2D). The extent to which immune
activation, β cell dysfunction, and insulin resistance occur following AP and the metabolic, imaging, and genetic
correlates of these phenotypes have not been well characterized. The Type 1 Diabetes in Acute Pancreatitis
Consortium (T1DAPC) was formed in 2020 and tasked participating clinical centers (CC) with proposing studies
to address these knowledge gaps. The Indiana University CC is a key contributor to the T1DAPC and the
consortium’s primary study, DREAM (Diabetes Related to Acute pancreatitis and its Mechanisms). DREAM is a
multicenter, observational cohort study prospectively enrolling adults with a recent episode of AP to investigate
the incidence, etiology, and pathophysiology of DM following AP, with emphasis on the autoimmune processes
that result in T1D. Participants undergo prospective characterization of glycemic status, islet function, and β cell
autoimmunity, as well as serial collection of clinical data, biological specimens, and imaging data to address a
number of scientific objectives. In this renewal application, we propose the following specific aims (SA) to meet
the goals of RFA-DK-25-017 and the successful renewal of the T1DAPC Consortium: SA #1: Continue our
contributions to DREAM. We will utilize state-of-the-art immunologic phenotyping and measurements of β cell
function to define the physiologic basis for metabolic dysregulation in DM after AP. In tandem, a biorepository is
being developed for undertaking translational, mechanistic, and biomarker investigations. SA #2: Continue our
contribution to the T1DAPC ancillary study “DREAM: Metabolic Outcomes Using Novel CGM Metrics” (DREAM-
ON). The primary objective of DREAM-ON is to determine whether continuous glucose monitoring (CGM) can
predict risk for developing pre-DM and DM or the need for insulin therapy among those who develop DM and
whether CGM can provide insight into the pathophysiology and DM subtype following an episode of AP. SA #3:
Continue our participation and leading role in the research magnetic resonance imaging (MRI) arm of DREAM,
“Imaging Morphology of Pancreas in Diabetic Patients following Acute Pancreatitis” (IMMINENT). IMMINENT
utilizes novel quantitative MRI techniques as a non-invasive biomarker to identify patients at risk for DM post-
AP. This longitudinal study evaluates pancreatic parenchymal morphologic and pathophysiologic changes
following AP in euglycemic, pre-DM, and DM individuals. Imaging phenotypes will be correlated with metabolic
and immunological phenotypes. SA #4: Determine whether genetic variation and T1D and T2D genetic burden
influence diabetes risk and phenotype following an episode of AP. We hypothesize that underlying genetic
variation may provide insight into the risk of developing islet-associated autoimmunity and DM post-AP and
could, in part, explain the continuum of metabolic phenotypes observed.

Public health relevance
PROJECT NARRATIVE Diabetes mellitus (DM) is a known complication of acute pancreatitis (AP); however, knowledge gaps remain in our understanding of the incidence, risk factors, pathophysiology, and best management of DM following an episode of AP. Since network inception in 2020, the Indiana University Clinical Center has been an active contributor and collaborator in the Type 1 Diabetes in Acute Pancreatitis Consortium (T1DAPC), in which “Diabetes RElated to acute pancreatitis And its Mechanisms” (DREAM) is the primary study. In the current proposal, submitted in response to RFA-DK-25-017, we are targeting renewal of the Indiana University T1DAPC Clinical Center to provide the resources and collaborative opportunities necessary for ongoing enrollment of well- characterized individuals in DREAM and other consortium studies, with the aim of furthering our understanding of critical knowledge gaps surrounding the development of DM after AP.